Ethanol Consumption and Muscarinic Tone in Medial Septum

in the format shown below. Role on Project Principal Investigator No Form page 2 _ AJ_014698 Principal Investigator/Program Director (Last, first, middle): Yeh, Hermes H. The name of the pdncipal invesUgator/program director must be provided at the top of each printed page and each continuation page. RESEARCH GRANT TABLE OF CONTENTS Page Numbers Face Page ................................................................................................................................................ 1 Description,